Kmt2a/MLL1 regulation of endothelial activation

PROJECT SUMMARY / ABSTRACT
Excessive endothelial inflammation, ‘endotheliitis,’ is a hallmark pathologic feature of severe SARs-CoV2
infection. The sequalae of endotheliitis, such as microthrombosis and tissue hyperpermeability, culminate in a
maladaptive host response characterized by interstitial edema, tissue damage, and end organ dysfunction.
Despite advances in vaccines and antiviral treatments, the most severely ill patients suffering from SARs-CoV2
related endotheliitis have an elevated risk of mortality. There are currently neither specific medications
available to treat nor to prevent endotheliitis. Current therapies for severe SARs-CoV-2 infection are limited to
non-specific steroids, immunomodulators and anticoagulants: all are limited in clinical use due to significant
risk profile from off-target effects. Thus, a critical need exists for understanding specific regulators of the
dysfunctional endothelial response for development of targeted therapies. Utilizing human SARs-CoV2
specimens and multiple murine coronavirus models, we identify a novel role for histone methyltransferase
MLL1 in regulating gene expression central to the endotheliitis response: cellular adhesion molecules (CAMs)
and pro-coagulant mediators (PCMs). Through a series of experiments, we have identified specific signal
transducer and activators of transcription (STATs) as important drivers of viral-induced MLL1 expression and
IL-1 receptor-associated kinases (IRAKs) as key regulators of MLL1 degradation. Hence, we identified that the
imbalance of STAT-mediated expression and IRAK-mediated degradation of MLL1 augments viral
endotheliitis. These results have led to our hypothesis that endotheliitis gene expression in response to
coronavirus is mechanistically driven by the STAT-MLL1-IRAK pathway and promotes overt endothelial
activation, microthrombosis, and end-organ damage. We further postulate that endothelial homeostasis may
be restored via nanoparticle encapsulated MLL1 inhibitor targeted to the endothelial cells, resulting in
attenuation of viral-induced endotheliitis. This hypothesis will be investigated via the following specific aims:
Aim 1: To determine the mechanism(s) by which MLL1 targets endothelial CAMs and PCMs promotor
regions. Aim 2: To determine the role of STAT-1/3 in endothelial MLL1 induction and IRAK4 in MLL1
degradation. Aim 3: To determine functional impact of endothelial specific MLL1 inhibition on EC
adhesive characteristics and thrombotic propensity in vivo. Completion of these aims will increase our
mechanistic understanding of endothelial MLL1 as master regulator of endotheliitis-related genes in an
infectious context. The results from this proposal will define for the first time the ability of an endothelial-
targeted therapy to inhibit the pathologic features of severe SARs-COV2 infection.

Public health relevance
PROJECT NARRATIVE Endothelial inflammation occurs in the setting of severe COVID-19 infection, leading to organ dysfunction and thrombosis. We have recently identified that an increase in a histone methyltransferase, MLL1/Kmt2a, is responsible for altering the adhesive and thrombotic properties of the endothelial cell by enabling gene transcription. In this proposal we will understand the mechanisms that lead to increased MLL1 activity and test new cell targeted therapies to restore endothelial homeostasis.